Major histocompatibility complex gene editing to prevent hematopoietic stem cell graft rejection

PROJECT SUMMARY/ABSTRACT
Hematopoietic stem cell transplantation (HSCT) cures a large number of disorders caused by dysfunction
of blood-based cells. However, only the most severe cases undergo transplant due to risks of treatment-related
mortality (TRM). Graft-versus-host disease (GVHD), chemotherapy conditioning toxicity, and infections due to
low white blood cell counts from myeloablative conditioning are the primary drivers of TRM. Depleting T cells
from stem cell grafts markedly reduces GVHD, and conditioning the patient with anti-CD117 antibodies instead
of chemotherapy reduces organ toxicity and preserves the infection-fighting abilities of white blood cells. Thus,
the majority of HSCT TRM for could be resolved with a treatment paradigm combining T cell depletion from stem
cell grafts with anti-CD117 conditioning. However, preservation of host immune cells with this paradigm will lead
to rejection of donor stem cells. This project will answer critical questions related to new strategies for preventing
immune rejection of the stem cell graft. Specifically, we seek to investigate human leukocyte antigen (HLA)
matching between donor and recipient and develop ways to circumvent graft rejection due to mismatches. The
overarching hypothesis we will test in this proposal is that silencing of mismatched HLA by gene editing will
prevent immune-mediated rejection and enable stable engraftment of donor stem cells. This will be explored in
the context of HSCT with haploidentical related donors. Haploidentical related donors are HLA matched with the
patient at a minimum of half of the major HLA alleles, and are a near universally available donor type that
addresses the issue of most non-Caucasian patients not having full HLA match options in the National Marrow
Donor Program. In order to advance our long-term goal of developing HLA gene editing for prevention of graft
rejection in haploidentical related donor HSCT, we have determined that our efforts will need to be guided by first
answering 3 biological questions. Our first aim will be to test whether the reduction in DNA double strand break
signaling of next generation gene editing methods will yield greater HSC fitness and engraftment potential
compared to conventional Cas9-mediated knockout methods. Our second aim will be to determine whether
reductions in cell surface HLA through gene editing will affect antigen presentation to a degree where T cell
responses are negatively impacted. Our third aim will use a novel mouse model that recapitulates the genetics
of related donor haploidentical transplant to determine if silencing of mismatched major histocompatibility
complex is sufficient for preventing graft rejection, or if additional interventions to address NK cell, myeloid, and
minor histocompatibility complex contributions to graft rejection are needed. Upon completion of these aims, our
results will reveal critical information guiding the development of next generation HSCT approaches aimed at
reducing TRM and thereby expanding the number of patients and disease indications eligible for curative HSCT.

Public health relevance
PROJECT NARRATIVE Hematopoietic stem cell transplantation can cure a wide variety of blood disorders, but has limited scope of deployment due to risks of co-transplanted immune cells attacking the patient’s body and toxicity of the chemotherapy used to open up space in the bone marrow. New methods have been developed that limit these risks and toxicities, but unfortunately these methods also increase the risk of stem cells failing to successfully engraft and take up residence in the patient. This proposal will provide critical information needed to improve stem cell engraftment in the bone marrow when these new methods are used, thus increasing the number of patients that can safely receive a curative hematopoietic stem cell transplant.